Role of clonal somatic mutations in microglia activation and Alzheimer’s disease

Project Summary/Abstract
Alzheimer’s disease (AD) and other neurodegenerative diseases are characterized by age-related
onset and progressive neuronal loss. Neuroinflammation, the activation of the brain's innate immune system, is
known to be critically involved in the initiation and development of neurodegeneration. As the primary immune
cells in the brain, activated microglia have been recently reported to promote neuronal death during AD
pathogenesis, yet the mechanisms by which age and genetic risk interact remain largely unknown. Somatic
mutations accumulate in various cell types during the development and aging process of the human body.
Clonal expansion of certain cell populations, driven by somatic mutations in genes regulating cell proliferation,
has long been associated with an increased risk of cancer with age, but has only recently been linked to a
growing list of non-cancer neurological diseases. Notably, somatic BRAF mutation in the microglial lineage has
been implicated in histiocytosis-associated neurodegenerative conditions. Our preliminary results from two AD
cohorts and with two sequencing technologies consistently show an excess of clonal somatic mutations in AD
brains, particularly in proliferation-related genes of microglia.
This new study aims to examine if the accumulation of somatic mutations contributes to an age-related
increase of AD risk by activating clonal expansion of microglia, which subsequently induces neuroinflammation
and neuronal loss in AD brains. The first Aim of the study is to identify somatic mutations by re-analysis of the
existing bulk and single-cell RNA-seq datasets from large AD cohorts, and compare the transcriptome-wide
burden and distribution of somatic mutation between different brain regions of AD patients and age-matched
controls. In the second Aim of the study, molecule-barcoded ultra-deep panel sequencing will be applied to
screen for clonal somatic mutations more sensitively among genes that regulate cell cycle and proliferation in
AD and control brains, which will enable us to explore frequently mutated genes or pathways that may drive
the clonal expansion of carrier cells during AD pathogenesis. The third Aim of the study will focus on the
mutant fraction and functional impact of potentially pathogenic somatic mutations across different cell types in
AD brains, especially for microglia, by combining single-cell RNA-seq and PRDD-seq, a method we developed
for parallel analysis of somatic mutation and cell-type information from the same single-cells. The results of our
study will shed new light on the contribution of somatic mutation to increased AD risk, and highlight the clonal
expansion of microglia triggered by somatic mutations in proliferation-related genes as a potential mechanism
of AD pathogenesis.

Public health relevance
Project Narrative Alzheimer’s disease (AD) and other neurodegenerative diseases are characterized by age-associated neuronal loss, which involves neuroinflammation induced by activated microglia. Our preliminary analyses from two AD cohorts and with two sequencing technologies revealed a significant and consistent increase of clonal somatic mutations in AD brains, particularly in proliferation-related genes of microglia. We plan to test our hypothesis that the accumulation of somatic mutations contributes to an age-related increase of AD risk by activating clonal expansion of microglia, which subsequently induces neuroinflammation and neuronal loss in AD brains.